Advancing Resource & Research Opportunities in Environmental HealthSciences (ARRO-EHS)”

PROJECT SUMMARY/ABSTRACT
Salish Kootenai College (SKC) is a top tribal college that provides quality postsecondary
education for Native Americans in Montana and across the US. Previous funding has allowed
the SKC Life Sciences department to build a nascent Bachelor of Science program with a
Cell/Molecular Biology track and most recently an Environmental Health Sciences track.
Currently, it is the only program at a tribal college simultaneously offering both of these tracks
while emphasizing place-based research experiences for a vastly underrepresented minority
population across all scientific disciplines. Support of the current proposal “Advancing Resource
& Research Opportunities in Environmental Health Sciences (ARRO-EHS)” will further strengthen
an intensive academic and research ecosystem at SKC resulting in more competitive Native
American students for advanced degree programs in environmental health sciences. To
accomplish this, ARRO-EHS seeks to train up to 15 students over five years with the following
aims: 1) ASSOCIATE underrepresented students to an enhanced educational environment using
innovative student resource tools, continuous one-on-one mentoring with faculty and peers, and
wellness initiatives to promote student engagement, retention, and outreach opportunities to the
larger reservation community; 2) ACHIEVE environmental health science-focused and faculty
mentored internal undergraduate experiences that utilize High Impact Practices such as
competitive student-inspired research projects, CUREs (Course-based Undergraduate Research
Experiences) infused with novel cultural/traditional tribal knowledge, and a curriculum
supplemented with renowned guest speakers in environmental health sciences; and 3)
ADVANCE students to graduate programs through external research internships with existing and
new Tier-1 partnerships, better preparation for graduate program entry, and an “Indigenous
Leaders in Science” workshop to facilitate a diverse work force with confident and capable leaders
in the field of environmental health sciences with a unique tribal, environmental, and community
perspective.

Public health relevance
PROJECT NARRATIVE Native Americans are a vastly underrepresented minority population across all scientific disciplines. Herein, “Advancing Resource & Research Opportunities in Environmental Health Sciences (ARRO-EHS)” proposes to strengthen the academic and research ecosystem at Salish Kootenai College (SKC), a Native American serving tribal college, resulting in more competitive students for advanced degree programs in environmental health sciences. The program also proposes to promote a more diverse work force in the field of environmental health sciences through the training of confident and capable leaders with a unique tribal, environmental, and community perspective.